Baylor-Johns Hopkins Center for Mendelian Genetics

SUMMARY OF PARENT AWARD: In its 7th year of funding, the Baylor-Hopkins Center for Mendelian Genomics (BHCMG) aims to identify high penetrance variants causing Mendelian phenotypes in all the protein-coding genes in the human genome. To this end we have recruited samples from > 70 countries around the globe and used whole exome sequencing (WES) coupled with whole genome SNP arrays to search for the responsible genes and causative variants. Currently, we have studied >550 phenotypes and performed ~10,000 exomes and identified 107 novel Tier 1 genes and 251 Tier 2 genes. To facilitate this effort, we have developed and utilized PhenoDB, GeneMatcher and a variety of other software tools. Our results have been disseminated in 218 publications and by distribution of data in ClinVar and dbGaP.

Public health relevance
We have formed a partnership between two distinguished programs in human genetics, The Baylor – Hopkins Center for Mendelian Genomics or BHCMG, to recruit patients with Mendelian disorders. We continue to use state of the art genetics and genomics technology and analyses to identify the genes and variants responsible for these disorders and disseminate our results to the biomedical community.